Administrative Core

Administrative Core Project Summary The Administrative Core for this P50 includes the 1) Program Director, 2) a Grants Manager, 3) a Subject Coordinator and 4) a Biostatistician co-investigator and his assistant. An External Advisory Committee comprised of three senior scientists with highly relevant expertise will provide oversight of the Center's scientific progress and will guide the research plan when appropriate. The purposes of this Administrative Core are to: Aim 1: Provide leadership and administrative oversight of projects and progress Aim 2. Foster inter-project collaboration and interactions with External Advisors Aim 3. Manage shared resources and resolve conflicts